7T MRI as a potential tool for detection of pathology in Alzheimer's disease

Project Summary/Abstract
Amyloid-beta (Aβ) is a small piece of a larger protein called amyloid precursor protein. It accumulates in
stages into microscopic amyloid plaques that are considered a hallmark of a brain affected by Alzheimer’s
disease (AD). Positron emission tomography (PET) is an established technique to detect Aβ plaques in vivo.
Some preclinical and postmortem data report an accumulation of redox-active iron near Aβ plaques.
magnetic resonance imaging (MRI) of Aβ plaques has been attempted using various techniques, notably
with susceptibility contrast. The non-invasive detectability of Aβ plaques in MRI has so far been largely
attributed to iron deposition accompanying Aβ plaques. It is believed that the susceptibility shortening
effects of paramagnetic iron are the primary source of contrast between plaques and surrounding tissue. We
hypothesized that aggregations of iron associated Aβ would increase electron density and induce notable
changes in local susceptibility value. Due to higher susceptibility at ultra-high field (UHF) strengths, induced
iron susceptibility is large enough to generate contrast relative to surrounding normal tissues that can be
visualized by quantitative susceptibility techniques at 7 Tesla (7T) MRI.
The goal of this proposal is to bring forward an alternative platform for analysis of pathologic
biomarkers in AD patients, thanks to ultrahigh field (7T) MR neuroimaging. The development of
specialized sequences for 7T susceptibility MRI will enable the comparison and microstructural data in AD
patients at an unprecedented resolution; this, in turn, will provide a deeper understanding of the in vivo
pathophysiology of AD and allow us to potentially identify a set of susceptibility-based markers of disease
pathology. Specifically, we expect our integrated approach to help us validate UHF MRI as a unique tool to
improve AD diagnosis and prognostic measurements. Our central hypothesis is that UHF MRI provides a
unique and powerful measure of changes associated with AD in the brain, and may be integrated with
existing neuroimaging tools to achieve unprecedented visualization of the consequences of disease
pathology.
This career development project also includes a training plan designed to refine and address gaps in the
applicant’s technical and scientific knowledge and experience, develop his research career skills, expose
him to the neuroimaging and neuroscience communities, and lay the groundwork for his career as an
independent scientist. The training plan encompasses: coursework in neurological disorders, clinical
neuroscience, research grant applications, and budget management; presentation of his work at technical
MRI and neuroscience conferences; delivery of formal classroom lectures and small-group teaching
sessions; mentorship of research volunteers; organizing a research symposium; and hands-on training
during the conduct of the research project.

Public health relevance
Project Narrative Early diagnosis of Alzheimer’s disease (AD) is still challenging, because of the subtlety of the microstructural changes it initially causes in the brain and the difficulty of identifying them with traditional neuroimaging techniques such as PET or CT, and MRI (1.5T, 3T) scans. Recent evidence has revealed that one of the neurodegeneration hallmarks of AD, amyloid-beta plaques is associated with iron accumulation, which can be quantified in vivo through susceptibility MRI techniques. In this proposal, we bring forward a new alternative framework using ultra-high resolution, MR neuroimaging at 7T, wherein this approach will enable the analysis of pathologic markers in AD patients and bring novel insights in our understanding of the mechanisms of AD onset and progression.